State Policy Classification System & Policies that Influence the School PE & Nutr

The purpose of this IAA is to provide the mechanism whereby the National Cancer Institute (NCI) will reimburse the Program Support Center (PSC) to award and administratively manage the State Policy Classification System and Policies that Influence the School Physical Education and Nutrition Environment contract with the Maya Tech Corporation. The objectives of this task order are to (1) identify and analyze physical education- and nutrition-related statutes and regulations for the years 2008, 2010, and 2012; (2) refine the existing physical education classification system to include a physical activity scale and update based on new national recommendations; (3) refine the existing nutrition classification as appropriate; (4) to assist with making the data collected from 2003 to 2012 publicly available for analysis.